Defining and exploiting the plasticity transcriptome to repair the damaged spinal cord

SUMMARY
A century of research has shown that the adult central nervous system is incapable of self-repair after injury or
disease. Indeed, adults with traumatic spinal cord injuries maintain chronic functional deficits that impact all
aspects of their lives. However, increasing evidence suggests that the adult CNS retains some ability to initiate
a growth program and functionally re-organize in response to activity, experience and mild trauma and
particularly after intensive rehabilitative therapy. In this proposal we have used in vivo viral tracing in
combination with FACS and single cell RNA sequencing to develop a comprehensive anatomical and
molecular atlas of the adult corticospinal tract (CST). We plan to leverage this atlas to define the molecular
mechanisms that drive axon growth in specific subsets of corticospinal tract neurons during rehab in the
presence and absence of the axon growth inhibitors nogo receptor-1. We believe that a comprehensive
understanding of the intrinsic molecular mechanism that initiates and sustains rehab-mediated axon growth
within defined subsets of CST neurons can then be exploited to design novel therapies to repair the acutely
and chronically damaged spinal cord.

Public health relevance
NARRATIVE There are no effective treatments for spinal cord injury (SCI). The financial and emotional burden these injuries have on patients and their families highlights the urgent clinical need for maximally adaptive and minimally maladaptive potent repair strategies. The aim of this proposal is to explore the molecular machinery that drives rehabilitation mediated recovery of function after SCI and determine whether this intrinsically mediated axon growth program can be exploited to more comprehensively restore function after severe acute and chronic SCI.